Mechanisms and Regulations of kappa Opioid Receptor Signaling

Opiates have been widely prescribed for pain management in the US, with a staggering 142 million prescriptions
in 2020 alone. While these drugs effectively relieve pain by interacting with the mu opioid receptor (MOR), their
complex pharmacology has led to concerning side effects such as abuse potential, respiratory depression, and
addiction risks. In fact, opioid overdose has become a leading cause of death in the US, with more than 100,000
reported deaths in 2021. Consequently, there is a growing need to explore alternative treatments for pain and
related conditions. One highly promising therapeutic target is the kappa opioid receptor (KOR), which not only
addresses pain but also offers potential benefits in tackling affective disorders and addiction. This proposal aims
to identify the mechanisms and regulators that control KOR signaling and potentially overcome the limitations
and side effects associated with traditional opioids by targeting novel signal transducers. The KOR signals
through seven Gαi subtypes (Gi1, Gi2, Gi3, GoA, GoB, Gz, and Ggustducin (Gg)) and two β-arrestins (β-arrestin1
and β-arrestin2). These G proteins consist of Gα, Gβ (Gβ1-5), and Gγ (Gγ1-13) subunits, forming heterotrimer
complexes. Recently, we reported the structures of KOR in complex with four different G protein subtypes (Gi1,
GoA, Gz, and Gg), which shed light on KOR receptor activation and signaling. Each G protein subtype has been
found to play distinct roles in opioid-mediated responses. Functional characterization has also revealed
significant differences among the four G protein subtypes. Moreover, our preliminary studies have identified that
different combinations of Gβ and Gγ subunits can significantly influence the signaling profile of individual Gα
proteins by affecting the stability of the Gα-Gβ-Gγ complex. Additionally, GPCR kinases (GRKs), such as GRK2,
play a crucial role in terminating G protein signaling, promoting receptor internalization, and degradation.
Interestingly, we have discovered that GRK2 not only directly interacts with KOR and phosphorylates it but also
forms a stable complex with Gβ1Gγ2 and KOR, suggesting a previously unknown role of GRKs. Furthermore,
using proximity labeling (APEX) combined with mass spectrometry (MS), we have identified ligand-specific
signaling profiles engaged by specific G protein signaling. These findings indicate that individual signaling events
mediated by different transducers may separately contribute to the therapeutic efficacy and side effects
associated with KOR. Our central hypothesis is that the ligand-specific responses at KOR are determined by
complex, non-traditional signaling networks at the cellular level. To test this hypothesis, we propose the following
studies. Aim 1. Define the role of non-traditional regulators in KOR-G protein signaling. Aim 2. Identify the
molecular determinants of GRK subtype selectivity in KOR signaling. Aim 3. Profile protein-protein interaction
networks in ligand-dependent cellular signaling response of KOR. The goal of these studies will be a more
detailed understanding of the molecular pharmacology of KOR, therefore providing the opportunity for gaining
new insights into the chemical biology of KOR and access to new chemical modulators as opioid alternatives.

Public health relevance
Narrative The kappa opioid receptor (KOR) is a highly desirable therapeutic target capable of treating not only pain but also affective disorders and addiction. Non-traditional signaling effectors and pathways underlying KOR activation play important roles in ligand-specific responses. Identifying the key triggers and mediators involved in KOR signaling will provide new routes for developing modulators of KOR as opioid alternatives.